Neural correlates of fear conditioning and extinction in veterans with PTSD and alcohol use disorder

Approximately half of all treatment seeking Veterans with posttraumatic stress disorder (PTSD) have
problems with alcohol, yet it is unclear how current alcohol use affects critical processes mediating recovery from
trauma. Despite strong preclinical evidence that recent, heavy alcohol exposure adversely impacts fear
extinction, and that fear extinction is central to recovery from PTSD, the direct effects of current, problematic
alcohol use on fear extinction have not been characterized in those with PTSD and alcohol use disorders
(PAUD). Similarly, contextual fear processing, or the accurate discrimination of threat in the environment, is
implicated in the maintenance of PTSD but has never been explored in PAUD. Severe symptom profiles, small
treatment gains, and high treatment dropout rates in Veterans with PAUD underscore the need to understand
the effects of current heavy drinking on the mechanisms of fear extinction and contextual fear processing.
Without studies accounting for the influence of alcohol on processes central to PTSD recovery, treatment
innovation for PAUD is likely to remain limited.
Previous work and preliminary data from our lab suggest that individuals with PTSD have specific deficits in
fear extinction and recall, and that the ventromedial prefrontal cortex (vmPFC), hippocampus (HPC), amygdala,
insula, and dorsal anterior cingulate cortex (dACC) play critical roles in the inhibition and expression of fear
processing. Moreover, our preliminary data show that current problematic alcohol use in the context of PTSD is
associated with higher treatment drop-out and fewer treatment gains from exposure-based relative to coping
skills therapy, potentially suggesting an extinction-specific impact of alcohol use on clinical outcomes. While
preclinical models provide compelling mechanistic evidence that chronic alcohol exposure disrupts fear
extinction and recall, as yet there is no clinical analogue to this work. Relatedly, contextual fear processing
is abnormal in PTSD, and damage to the hippocampus (HPC) impairs this process. Tasks used previously to
assess contextual fear processing may not reliably invoke HPC dependent processes, and none have assessed
the impact of alcohol despite the known deleterious impact of alcohol on HPC structure and function.
In the proposed design, we will compare Veterans with PTSD and ongoing, heavy alcohol use (“Drinking” or
D-PAUD) to those with 30- to 90-days of sustained abstinence (A-PAUD) using a validated 2-day protocol of
concurrent psychophysiological and functional brain imaging measures of fear acquisition, extinction learning,
extinction recall, as well as a newly validated configural threat learning measure of contextual fear processing
that invokes HPC dependent processes. We predict that Veterans with D-PAUD will show physiological response
indicative of greater fear recovery, and neural response consistent with decreased fear inhibition (i.e., less
vmPFC activation) during fear extinction learning and recall, and decreased contextual fear processing (i.e., less
HPC activation) relative to those with A-PAUD. We will also use directed-functional connectivity to identify neural
networks involved in fear extinction recall and to demonstrate differential group-related circuit adaptations, and
will employ computational predictive modeling to identify regions specifically tracking dynamic US expectations
and compare these patterns between the two clinical groups.
The proposed research will provide the first data on how current heavy drinking in the context of PAUD
affects fear extinction and contextual fear processing, which are central mechanisms of PTSD recovery, using
gold-standard and innovative approaches. Discovery of specific patterns of neural response can lay the
groundwork for the investigation of neuromodulatory and pharmacological interventions, as well as clinical trials
investigating the efficacy of existing or novel treatments that act at key mechanisms of recovery. In sum, the
proposed study will identify critical alcohol-specific mechanisms of impairment to provide a roadmap for the
development of targeted interventions to increase the efficacy, efficiency, and innovation of PAUD treatments.

Public health relevance
Roughly half of all treatment seeking Veterans with PTSD have problems with alcohol, however, the impact of excessive alcohol use on fear extinction and contextual fear processing—processes central to trauma recovery— is unknown. A clear understanding of how ongoing, problematic alcohol use interferes with the mechanisms of fear extinction and contextual fear processing could provide new targets for treatment development and help clinicians and Veterans alike understand how continued problematic drinking may impact exposure-based treatment gains. We propose to use gold-standard and innovative physiological and functional neuroimaging measures to determine the impact of current, heavy alcohol use versus abstinence on the mechanisms of fear extinction and contextual fear processing in Veterans with PTSD and alcoholism. The proposed study will identify critical alcohol-specific mechanisms of impairment to provide a roadmap for the development of targeted interventions to increase efficacy of PAUD treatments.